SAXS Facility

The summary is shown here in terms of publications: ===============2025============== 1 Stagno, J. R., Deme, J. C., Dwivedi, V., Lee, Y. T., Lee, H. K., Yu, P., Chen, S. Y., Fan, L., Degenhardt, M. F. S., Chari, R., Young, H. A., Lea, S. M. and Wang, Y. X. Structural investigation of an RNA device that regulates PD-1 expression in mammalian cells. Nucleic Acids Res 53, doi:10.1093/nar/gkaf156 (2025). 2 Milligan, J. J., Strader, R. L., Chakrabarty, A., Ney, M., Sirohi, P., Su, J. C., Varanko, A. K., Shmidov, Y., Tsolova, K., Fontes, C. M., Finkelstein, A., Mattikalli, R., Wang, Y. X., Fan, L., Li, X., Nair, S. K. and Chilkoti, A. Controlling Release Kinetics of an Adjuvant from a Depot Improves the Efficacy of Local Immunotherapy in Metastatic Cancer. Adv Sci (Weinh), e03591, doi:10.1002/advs.202503591 (2025). 3 Maciag, A. E., Yang, Y., Sharma, A. K., Turner, D. M., DeHart, C. J., Abdelkarim, H., Fan, L., Smith, B. P., Kumari, V., Dyba, M., Rigby, M., Castillo Badillo, J. A., Adams, L., Fornelli, L., Fox, S., Brafman, A., Turbyville, T., Gillette, W., Messing, S., Agamasu, C., Wolfe, A. L., Gysin, S., Chan, A. H., Simanshu, D. K., Esposito, D., Chertov, O., Stephen, A. G., Arkin, M., Renslo, A., Kelleher, N. L., Gaponenko, V., Lightstone, F. C., Nissley, D. V. and McCormick, F. Blocking C-terminal processing of KRAS4b via a direct covalent attack on the CaaX-box cysteine. Proc Natl Acad Sci U S A 122, e2410766122, doi:10.1073/pnas.2410766122 (2025). 4 Lee, Y. T., Degenhardt, M. F. S., Skeparnias, I., Degenhardt, H. F., Bhandari, Y. R., Yu, P., Stagno, J. R., Fan, L., Zhang, J. and Wang, Y. X. The conformational space of RNase P RNA in solution. Nature 637, 1244-1251, doi:10.1038/s41586-024-08336-6 (2025). 5 Degenhardt, M. F. S., Degenhardt, H. F., Bhandari, Y. R., Lee, Y. T., Ding, J., Yu, P., Heinz, W. F., Stagno, J. R., Schwieters, C. D., Watts, N. R., Wingfield, P. T., Rein, A., Zhang, J. and Wang, Y. X. Determining structures of RNA conformers using AFM and deep neural networks. Nature 637, 1234-1243, doi:10.1038/s41586-024-07559-x (2025). ===============2024============== 2 Zhu, Y., Chaubey, B., Olsen, G. L. and Varani, G. Structure of Essential RNA Regulatory Elements in the West Nile Virus 3'-Terminal Stem Loop. J Mol Biol 436, 168767, doi:10.1016/j.jmb.2024.168767 (2024). 3 Zhang, Y., Xu, Z., Xiao, Y., Jiang, H., Zuo, X., Li, X. and Fang, X. Structural mechanisms for binding and activation of a contact-quenched fluorophore by RhoBAST. Nat Commun 15, 4206, doi:10.1038/s41467-024-48478-9 (2024). 4 Skeparnias, I., Bou-Nader, C., Anastasakis, D. G., Fan, L., Wang, Y. X., Hafner, M. and Zhang, J. Structural basis of MALAT1 RNA maturation and mascRNA biogenesis. Nat Struct Mol Biol, doi:10.1038/s41594-024-01340-4 (2024). 5 Lee, Y. T., Degenhardt, M. F. S., Skeparnias, I., Degenhardt, H. F., Bhandari, Y. R., Yu, P., Stagno, J. R., Fan, L., Zhang, J. and Wang, Y. X. The conformational space of RNase P RNA in solution. Nature, doi:10.1038/s41586-024-08336-6 (2024). 6 Kim, M., Le, M. T., Fan, L., Campbell, C., Sen, S., Capdevila, D. A., Stemmler, T. L. and Giedroc, D. P. Characterization of the Zinc Uptake Repressor (Zur) from Acinetobacter baumannii. Biochemistry-Us, doi:10.1021/acs.biochem.3c00679 (2024). 7 Degenhardt, M. F. S., Degenhardt, H. F., Bhandari, Y. R., Lee, Y. T., Ding, J., Yu, P., Heinz, W. F., Stagno, J. R., Schwieters, C. D., Watts, N. R., Wingfield, P. T., Rein, A., Zhang, J. and Wang, Y. X. Determining structures of RNA conformers using AFM and deep neural networks. Nature, doi:10.1038/s41586-024-07559-x (2024). 8 Caba, C., Black, M., Liu, Y., DaDalt, A. A., Mallare, J., Fan, L., Harding, R. J., Wang, Y., Vacratsis, P. O., Huang, R., Zhuang, Z. and Tong, Y. Autoinhibition of ubiquitin-specific protease 8: insights into domain interactions and mechanisms of regulation. J Biol Chem, 107727, doi:10.1016/j.jbc.2024.107727 (2024).